Pathways to Negotiating Genomics Research Partnerships

Centering stakeholder perspectives in bioethics is critical to promoting research on the ethical development and deployment of emerging biotechnologies. Building capacity for more effective and relevant bioethics requires not only engagement with multidisciplinary scholarship but also scholars in other disciplines and fields adjacent to bioethics. Few mechanisms exist for supporting sustained and substantive dialogue on how to promote reciprocal and mutually beneficial research partnerships and applying these frameworks to real-world efforts in the development and deployment of biotechnologies. This project addresses this gap by creating structured and multidisciplinary explorations of frameworks that promote reciprocal and mutually beneficial partnerships, and to develop a network of stakeholders in bioethics. Our proposal aims to build capacity in bioethics research through sustained and systematic multidisciplinary explorations, dialogues, and the development of educational materials on frameworks that promote reciprocal and mutually beneficial partnerships. To achieve this, we have two objectives: 1) create a hybrid series including virtual monthly sessions that will feature speakers whose scholarship focuses on theories and frameworks that promote reciprocal and mutually beneficial partnerships, and convene scholars from disciplines beyond bioethics to engage these theories and frameworks and their applications in research of the development and deployment of biotechnologies, including in genomics, AI, and precision medicine; and 2) develop and disseminate educational resources to train scholars and scientists to engage research questions on the ethical development and deployment of emerging biotechnologies through a publicly accessible website dedicated to disseminating recordings of didactic presentations, synchronous group discussions, curated literature collections and other related resources.

Public health relevance
This project aims to build capacity in bioethics through structured and multidisciplinary explorations of frameworks that promote reciprocal and mutually beneficial research partnerships and their applications to the ethical development and deployment of biotechnologies, including in genomics, AI and precision medicine. We will create a hybrid series and educational resources to support bioethics research and researchers.